in situ Epigenetic Profiling of Single Cells in Kidney

Project Summary/Abstract
The goal of this proposal is to develop and validate two tools for in situ analysis of epigenetic state and
chromatin organization in single cells in kidney tissue. The first tool is based on our recently developed
technology SCEPTRE (Single-Cell Evaluation of Post TRanslational Epigenetic encoding) established for
cultured cells that will be adapted for use with kidney tissues in order to directly resolve and quantify histone
modifications at specific DNA loci in situ in single cells. The second tool is a new method called APT-FISH
(Amplified Probes from Tagmentation Fluorescence in situ Hybridization) that is designed to profile changes to
open chromatin. Each of these tools will be used concurrently with super-resolution expansion microscopy
imaging in order to directly relate nanoscale renal physiology to chromatin or epigenetic state and they will be
applied to the study of aging and senescence in kidney tissue.

Public health relevance
Project Narrative The kidney is a complex organ whose essential roles include filtering waste from the blood, regulating blood pressure, and maintaining electrolyte balance. This project will develop a microscopy-based technique to study the organization of the genome of kidney cells and it will use the new technique to study aging in model mouse kidney tissue. The tools and findings of this project will enable researchers to study genome organization in kidney or other tissues and will illuminate the molecular details of aging.